Developing a Culture of Biomedical Research at the University of the Virgin Islands

PROJECT SUMMARY
This proposal will enhance and innovate the biomedical research infrastructure and training at the University of
the Virgin Islands (UVI), the only higher educational institution in the US Virgin Islands (USVI). The overall objective
of this proposal is to provide the highest level of sponsored program services for biomedical research by
developing a culture of research through training, mentoring, collaboration and a strong infrastructure. UVI’s
vision is to develop research resulting in an increase in the number of faculty conducting excellent externally
funded biomedical research who will be able to mentor undergraduate students with potential for careers in
science. There are several motivating factors for this project: (1) Diversity in the scientific workforce is key to the
future biomedical discoveries that will improve the health of the Nation, and HBCUs such as UVI have an
important role to play in training students who are underrepresented in science. (2) The USVI is a medically
underserved area that experiences dramatic health disparities and emerging diseases including dengue,
chikungunya, Zika, and the more recent coronavirus, which are important not only in the Caribbean but are also
increasing on the US mainland. Little research on population health has been performed in the USVI and UVI
continues to look at research in these areas. (3) Extensive undergraduate research experience is essential to
prepare students for highly competitive doctoral programs. Although UVI has very successful programs that
mentor undergraduates in research, there are many more UVI students interested in research experience than
can be accommodated in externally funded research laboratories. (4) UVI has established a culture of innovation in
its 2018-2023 Strategic Plan and through this research infrastructure and innovation is a primary focus area and is
supported by the President and senior leadership. The UVI Institutional Development Plan (IDP) addresses barriers
to research and informs the Specific Aims of this proposal: (1) Develop UVI’s research administration leadership
and organization such that it is well-trained, resourced, and motivated to support a culture of research. (2)
Develop research review and training programs for research faculty to increase the number and improve the
competitiveness of proposal submissions (3) Increase mentorship and training opportunities for undergraduates in
biomedical research by supporting faculty to receive external funding. This program is innovative because it will
fully integrate the IDP for research within UVI’s 2018-2023 Strategic Plan, providing strong institution-wide
commitment. Research and training innovations include targeted training initiatives covering the life cycle of
research, increased outreach efforts, training and grant writing initiatives and focus groups of HBCU research
administrators to overcome the barrier of geographic isolation. UVI’s logic model will be used to ensure that
each activity will contribute to a sustainable vision for research and to developing a University-wide culture
supporting research.

Public health relevance
PROJECT NARRATIVE The development of a biomedical institutional culture of research is relevant to public health for two reasons. First, it will increase faculty participation in research in a medically underserved US Territory with a largely minority population that experiences health disparities in a unique environment. Second, the faculty will train and mentor underrepresented undergraduates providing them with the background necessary to thrive in highly competitive doctoral programs.